Organization and Function of the Periactive Zone

PROJECT SUMMARY
Membrane trafficking machinery plays pivotal roles in neuronal development, physiology, and neurological
disorders. In particular, canonical endocytic proteins regulate diverse cell biological processes at synapses,
including synaptic vesicle recycling, growth factor receptor traffic, synaptic adhesion, and neuropeptide
secretion. At synapses much of this machinery accumulates at high concentrations in a specialized micron-
scale membrane domain called the periactive zone (PAZ), suggesting the presence of synapse-specific
organization and regulatory mechanisms. We do not understand how this structure is assembled, or how the
synapse directs subsets of PAZ proteins to particular cell biological functions in space and time. The goal of
this proposal is to identify new synapse-specific mechanisms that deploy the PAZ machinery to diverse cell
biological processes to promote normal synapse development and function in vivo. To meet this goal, we
propose to investigate the mechanisms that promote PAZ assembly and control its cell biological functions
using two model systems in Drosophila – the larval neuromuscular junction and neurons regulating the
circadian clock. In these studies, we will combine cutting edge live and super-resolution imaging, image
analysis, and mechanistic separation-of-function perturbations to understand PAZ regulation and function at
molecular, cellular, and behavioral scales. We will extend our mechanistic insights from the neuromuscular
junction into the central nervous system to determine how PAZ cell biological functions control the
development and function of circadian pacemaker neurons in vivo. Aim 1 will characterize how the PAZ
assembles during developmental, activity-induced, and circadian synapse formation, and identify how synaptic
adhesion molecules regulate PAZ assembly and organization. Aim 2 will determine how combinations of PAZ
proteins regulate neuropeptide secretion by controlling where, when, and how dense core vesicles dock and
fuse at the synapse. These investigations will inject fresh mechanistic insights into synapse-specific control of
the membrane trafficking machinery, and we expect that understanding these basic mechanisms will illuminate
specific, targetable links between these conserved proteins and diverse neurological and neurodegenerative
disorders.

Public health relevance
PROJECT NARRATIVE Neurons communicate with each other by releasing different types of membrane-bound packets of signaling molecules, and then recycling the membrane and packaging machinery for new rounds of release. This proposal will explore how the proteins that control these events are organized and work together in a specialized region of the neuron called the periactive zone. Periactive zone proteins are implicated in many neurological diseases, and learning how they are deployed at synapses will help us understand these diseases and develop cures.